Catalyzing Cancer Research among Urban Underrepresented Minority Youths and Teachers (CATALYST)

Project Summary
West Baltimore is comprised of majority minority communities that are among the most economically and
academically disadvantaged in the US and are disproprotionately impacted by cancer. A healthcare and cancer
research workforce that understands the challenges facing West Baltimore residents and similar communities
across the US is essential to addressing cancer incidence and outcome disparities. To excite and sustain
underrepresented minorities (URM) scholars’ interest in cancer-related science subjects, healthcare research
and careers, early educational intervention that takes account of the social determinants of educational success
is critical. In this Catalyzing Cancer Research among Urban Underrepresented Minority Youths and Teachers
(CATALYST) program, we will implement an innovative and immersive program for Middle School scholars, their
families, teachers, and communities in West Baltimore.
The aims of the program are to: 1) Excite scholars, their families, and communities about cancer research using
cancer-focused research experiences and mentoring programs from an early stage in their education. 2) Develop
novel curricula and individually mentored, hands-on cancer research training and experiences for Baltimore Mid-
dle School teachers that are aligned with scholars’ curriculum and lead to improved science learning. 3) Develop
and implement novel scholars’ curricula integrated with research experiences to improve science learning in
Middle Schools. And 4) Expand the rich tapestry of outreach and community engagement activities to include
cancer-related research trainings in West Baltimore’s Middle Schools. Scholars and teachers’ projects will pro-
vide cancer-focused material for use in community outreach and engagement activities to be implemented by
the scholars and teachers in their schools and communities. The outcomes of scholars’ and teachers’ educa-
tional activities, curriculum development, and research projects will be published in peer-reviewed journals and
presented at local, regional, and national forums as well as during collaborative exchanges with peer NCI YES
programs across the US.
CATALYST is built on the highly successful University of Maryland Baltimore Continuing Umbrella of Research
Experiences (UMB CURE) Middle Schools Pilot Program – the first NCI CURE Middle School program – which
was implemented by the University of Maryland Greenebaum Comprehensive Cancer Center (UMGCCC) in
West Baltimore for seven years. The UMB CURE pilot developed a robust cancer-focused program that lever-
aged strong UMB and UMGCCC resources in a holistic approach to scholars’ education, and community's needs,
and is the framework for the proposed CATALYST program. The impact of CATALYST on all program stake-
holders will be rigorously evaluated and outcomes will be longitudinally tracked. This data will inform best prac-
tices and identify areas for improvement which is fed back to develop a sustainable and scalable program that
produces the next generation of URM cancer researchers and caregivers and ultimately increase diversity in the
biomedical workforce.

Public health relevance
NARRATIVE. The Catalyzing Cancer Research among Urban Underrepresented Minority Youths and Teachers (CATALYST) program expands upon seven years of a successful intervention pilot to excite middle school (MS) students from disadvantaged West Baltimore communities about cancer-related STEM subjects and careers. CATALYST will incorporate cancer research experiences for teachers that are used to develop MS curriculum and community outreach components. Integral to the success of this program is a holistic approach to address scholar, family and community needs that are essential for academic success. CATALYST scholars are part of a cancer-focused STEM education pipeline that will produce the next generation of researchers and healthcare professionals. This diverse workforce will stimulate innovation, enhance productivity and foster consideration of disparities issues in the fight against cancer.